Identification of small molecule inhibitors of USP18

The NCATS Early Translation Branch (ETB) hosts a broad and comprehensive program for the discovery of drug candidates directed towards rare diseases and pharmacological tools to probe the function of the human genome. ETB conducts research to understand the underlying principles driving the translation of basic research discoveries into tangible improvements in human health.

Identification and development of a USP18-specific small molecule inhibitor could assist to better define the roles of USP18 in cancer and immunity and to evaluate it as an anticancer target. During the reporting period, the collaborative team began development of an enzymatic assay to identify small molecule inhibitors of USP18. Screening hits will be validated in the primary assay and tested for specificity in cell-based orthogonal assays.